PRICE- Alcohol: Planning the Regional Implementation of a Culturally Adapted Brief Intervention for Alcohol for Tanzanian Emergency Departments

ABSTRACT
Alcohol use is rapidly increasing in low- and middle-income countries, where it is inexpensive, readily
available, poorly regulated, and there are few resources devoted to promoting safe alcohol use. Like
many other limited resource settings, there are few alcohol treatment facilities or addiction
practitioners in the Kilimanjaro region of Tanzania. For many in this setting, people only seek care
after an emergency condition. Our preliminary work suggests up to 30% of patients in the Emergency
Department have harmful or hazardous drinking behaviors. Our team has created a brief
negotiational intervention with a text based booster called the “Punguza Pombe Kwa Afya Yako
(PPKAY)/ Reduce Alcohol for Your Health.” Our recent pragmatic trial has demonstrated its
effectiveness at reducing alcohol use after an acute visit to the Kilimanjaro Christian Medical Center
in Moshi, Tanzania. As such, this program planning project plan for the regional implementation of this
intervention through mixed method site evaluations and co-design of final intervention,
implementation strategy and trial protocols with our Tanzanian partners. This will prepare us to
conduct an innovative hybrid implementation trial to implement this culturally adapted, resource
appropriate and evidence based intervention.

Public health relevance
Project Narrative Globally, alcohol causes more than 3 million deaths and is a leading avoidable risk factor. Currently, in low-resource settings like Tanzania, alcohol-related treatment and resources are scarce and our team has created an effective brief intervention to reduce alcohol use among patients at Kilimanjaro Christian Medical Center. This program planning project will conduct a mixed method feasibility assessment and co-design final intervention, implementation strategy and trial design work products to implement this innovative intervention in the Northern Tanzania region.